ALTERATIONS IN HYPOPITUITARISM AXES FOR GONADOTROPINS--WOMEN ENDURANCE TRAINING

Study the effects of chronic exercise on the mode of gonadotropin release in the late follicular phase. We predict that this phase will be greatly altered and that these alterations are proximate to luteal phase alteration. This prospective evaluation will assess the effect of acute exercise of two different intensities on the pulsatile properties of the gonadotropin release during the late follicular phase and its relationship to luteal phase.